Optimization of behavioral and biobehavioral interventions: Building investigator capacity nationwide

Project Summary
This application seeks renewal of funding for an R25 that is building nationwide investigator capacity in
optimization of behavioral and biobehavioral interventions. Multicomponent behavioral and biobehavioral
interventions play a central role across many areas of public health, including but not limited to substance
abuse disorders, HIV, cancer, and diabetes. To date, intervention science has relied primarily on the classical
treatment package approach, in which a set of intervention components is identified a priori, assembled into a
treatment package, and then immediately evaluated in a randomized clinical trial. Sole reliance on this
approach has prevented the field from addressing fundamental research questions—e.g., which components
are effective?—that are critical for development of interventions with sustained high public health impact.
Recently an innovative alternative has emerged called the multiphase optimization strategy (MOST). MOST, a
broad methodological framework for the principled optimization of interventions, is used to arrive at an
intervention that strategically balances effectiveness against affordability, scalability, and efficiency to ensure
that the intervention is practical to implement and therefore has the potential for sustained high public health
impact. Between 2016 and 2022, annual NIH funding awarded for projects involving intervention optimization
grew more than 450%, from about $30 million to about $144 million. At this writing, NIH has funded at least
245 projects related to MOST. We believe this growth has been enabled in part by the training efforts of the
previous R25. We prepared and placed 2 free comprehensive asynchronous introductory courses on the
Coursera platform, accessed by over 700 learners to date, and developed a synchronous virtual training aimed
at helping investigators gain the skill set they need to write successful funding applications and conduct high-
quality intervention optimization research. By the end of the first R25’s funding we expect more than 150
investigators will have completed our synchronous virtual training. In response to growing demand, we propose
to expand our training, outreach, and support efforts. Aim 1: We will continue to offer synchronous virtual
trainings, and coordinate with compatible existing NIH-sponsored training endeavors. Aim 2: In addition to
updating our existing offerings, we will offer exciting new courses on the Coursera platform. Aim 3: We will
enable investigators working with MOST to share the very latest findings, best practices, on-the-ground
experiences, and tips with each other by offering 12-16 informal webinars per year. Aim 4: We will provide
ongoing consultation, mentorship, support, and outreach for investigators at all career levels. Impact: The
proposed work will increase the number of investigators proficient in and funded for optimization of behavioral
and biobehavioral interventions. These investigators will, in turn, produce interventions that are effective,
readily implementable, and sustainable, i.e., have high public health impact, and thereby improve the nation’s
health in substance abuse, HIV, cancer, diabetes, and countless other important areas.

Public health relevance
Project Narrative The proposed work will develop training aimed at increasing the number of scientists proficient in and funded for optimization of behavioral and biobehavioral interventions. The work of these scientists will, in turn, produce more effective, efficient, economical, and scalable interventions, and thereby improve the nation’s health in substance abuse, HIV, cancer, and countless other important areas of public health.